MOSAIC: Targeting the Tissue State

SUMMARY: PROJECT 1: TARGETING GLIOMA TISSUE STATES
Glioblastoma (GBM) displays extensive cellular heterogeneity which represents a major obstacle for effective
treatment. This cellular heterogeneity not only consists of multiple tumor cell mutation factors that drive distinct
tumor cell behavior, but also impacts various non-tumor cells, contributing to tumor initiation, progression, and
treatment response. In fact, GBM’s microenvironment is multifaceted and consists of soluble factors, extracellular
matrix components, tissue-resident cells (neuron, astrocytes, endothelial cells, pericytes, etc.) and resident (e.g.
microglia) or recruited (e.g. bone-marrow derived macrophages) immune cells. Importantly, changes in the
cellular composition and cellular phenotypes can alter GBM tissue states to drive tumor growth and therapeutic
resistance. Thus, identifying the unique cellular composition and deciphering the multifaceted bidirectional
network between tumor cells and tumor microenvironment signals in various GBM tissue states can lead to
identification of novel therapeutic strategies.
Our preliminary studies using single nucleus RNAseq of pre- and post-treatment GBM has identified 3 tissue
states, corresponding to patterns of cohabitation of tumor and non-tumoral cell subpopulations. These
correspond to infiltrated brain, highly cellular proliferating tumor, and astrocytic / inflamed reactive tissue, which
is observed in the post-treatment samples and enriched in specific populations of myeloid cells and
mesenchymal glioma cells. Co-habitation of specific non-tumor cellular phenotypes in the glioma
microenvironment may influence glioma states signatures (astrocyte-like/mesenchymal, progenitor, proliferative)
that associate with tumor progression and therapeutic response. The goal of this project is to define the patterns
of cellular cohabitation associated with the tissue states and the cross-talk signals that influence local tissue
state, phenotypic expression, transitions and disease progression. Because of its known role in cross-talk
between specific populations in GBM, we will initially test the effects of targeting TWEAK-Fn14 signaling to drive
changes in tissue state. We hypothesize that targeting this as well as other key cross-talk signaling pathways
will induce tissue state transitions with corresponding alterations in cellular populations that will render tumors
more sensitive to therapeutic vulnerabilities and can be leveraged to slow tumor growth/progression.
To investigate the potential impact of such key states and their cross-talk, we propose three aims. Aim 1 focuses
on refining our understanding of glioma tissue states in both the pre- and post- treatment setting. Aim 2
investigates cross talk between the glioma cells and their microenvironment and how it may influence
progression. Aim 3 looks more locally at how cross-talk perturbations may impact tissue state transition.

Public health relevance
NARRATIVE: PROJECT 1: TARGETING GLIOMA TISSUE STATES Glioblastoma (GBM) biopsies are composed of not only molecularly aberrant malignant glioma cells but also a sizeable abundance of non-malignant cells (including immune, astrocytes, oligodendrocytes, etc.). The goal of this project is to find targetable cross-talk relationships between these cell compositional networks. Specifically, we will quantify different cellular compositions in pre- and post- treatment tumors, investigate cross-talk between the glioma cells and the microenvironmental other cell subpopulations, and, lastly, determine the impact of targeting this crosstalk to shift the cell community composition into a more favorable/treatable state.